Delineating the Function of TDP-43 in Skeletal Muscle Formation

PROJECT ABSTRACT/SUMMARY
Many degenerative neuromuscular diseases are associated with cytoplasmic accumulation of protein
aggregates. These aggregates are widely considered to contribute disease and thus are thought to be toxic to the
cell. Recently, we discovered similar aggregates, termed myo-granules, in healthy regenerating and
differentiating skeletal muscle. Myo-granules contain RNA and RNA-binding proteins. One prominent RNA-
binding protein found in myo-granules, TDP-43, is of particular interest due to its presence in aggregates
observed in degenerative disease. Further, myo-granules localize to developing sarcomeres and contain an
abundance of sarcomeric mRNAs that bear TDP-43 binding-sites. As the muscle regenerates and sarcomeres
are replaced, myo-granules are cleared and TDP-43 re-localizes to the nuclei. Together, these findings suggest
that TDP-43 may play a role in facilitating sarcomere formation and that accumulation of TDP-43 containing-
aggregates found in disease may not be the cause but instead the result of recurring attempts at skeletal
regeneration. In pre-liminary work, I found that TDP-43 deletion in muscle stem cells prevents differentiation,
identifying an essential role for TDP-43 in skeletal muscle. Specific Aim 1 will evaluate the role of TDP-43 in
myofiber formation and maturation during regeneration. To accomplish this, I will delete TDP-43 at
regenerative checkpoints for fusion of differentiated cells and for maturation of the regenerating muscle. The
results from aim 1 will be used to inform experiments in Specific Aim 2 where I will analyze the role of TDP-
43 in sarcomere formation. In pre-liminary work, TDP-43 deletion in differentiating cells during regeneration
results in muscle that is improperly repaired and myofiber size is drastically reduced. Additionally, myofiber
maturation is reduced when TDP-43 is deleted as indicated by the continued expression of developmental
sarcomeric proteins. Thus, is TDP-43 required for sarcomere regeneration and repair? I will ask this question
by taking an in vivo approach where TDP-43 will be deleted in both healthy and regenerating muscle to
evaluate the effect on sarcomere formation, maturation, and degradation. Delineating the function of TDP-43
in sarcomere formation should lead to a better understanding of the relationship between myo-granules and
disease-associated TDP-43 aggregates.

Public health relevance
PROJECT NARRATIVE Cytoplasmic aggregates that contain the RNA-binding protein TDP-43 are found in the skeletal muscle of patients with degenerative neuromuscular diseases and are assumed to be pathological. The experiments outlined in this proposal will delineate the function of TDP-43 in skeletal muscle formation. Identifying the function of TDP-43 in normal skeletal muscle function may shape our understanding of TDP-43 pathology in and how we treat patients with degenerative disease.